The Role of the Urban/Rural Divide and Socioeconomic Factors in the Incidence, Outcomes and Post-partum Care of Hypertensive Disorders of Pregnancy

PROJECT SUMMARY/ABSTRACT
In this proposal, we will quantify disparities in incidence, short- and long-term outcomes, and barriers to post-
partum care in women with hypertensive disorders of pregnancy (HDP) according to various demographic
factors and socioeconomic (SES) status indicators. HDP includes a broad spectrum of subtypes associated
with varying degrees of morbidity. Incidence of HDP and its complications are higher in rural areas and
socioeconomic status (SES) likely plays a moderating effect, but this has not been well-studied due to
challenges in determining individual-level SES. Our overall goal is to develop targeted strategies to improve
the cardiovascular health of women after HDP. This proposal strongly aligns with Goal 1 of the 2019-2023
Trans-NIH Strategic Plan for Women's Health Research "Advancing Science for the Health of Women”, which
aims to understand chronic conditions understudied among women and/or that disproportionately affect
populations of women who are understudied, underrepresented, and underreported in biomedical research –
specifically, women in rural areas and women who have low SES. We will use a novel indicator of SES, the
HOUsing-based Socioeconomic Status (HOUSES) index, which is an objective, scalable, standardized, and
individual-level SES measure that predicts multiple health outcomes. Our hypothesis is that SES may be an
important modifier of risk, with low SES causing a multiplicative increase in HDP incidence and outcomes,
regardless of place of residence.The following 3 aims are proposed to understand the intersection between
rural residence and SES in HDP. The first aim is to determine if SES is a significant moderator in the
relationship between urban/rural status and the incidence of HDP and its subtypes. We will quantify the
incidence of HDP subtypes in a 27-county region of the Upper Midwest, which has a large rural population,
using electronic health record data from 2000 to 2021 and test for interactions between urban/rural status and
SES. The second aim is to determine if SES is a significant moderator in the association between urban/rural
status and the risk of short and long-term complications of HDP. Using HDP cases identified in the first aim, we
will identify any cardiovascular and cardiometabolic diagnoses that develop after delivery and characterize
acute care and post-partum visits in the first year after delivery. We will test for interaction between rural/urban
status and SES and conduct a comprehensive cost analysis. The third aim will be to assess key barriers to
care for high-risk women with HDP complications through qualitative semi-structured interviews. We will
interview 30 demographically diverse women with adverse outcomes after HDP using the Health Belief Model
to understand barriers and facilitators of access to post-partum care. By combining the results of this
qualitative aim with the results from Aim 1 and 2, we can develop effective interventions that target high-risk
populations in rural areas and improve the care of women with HDP in the reproductive era and beyond.

Public health relevance
PROJECT NARRATIVE The goal of this proposal is to advance the cardiovascular health of women affected by hypertensive disorders of pregnancy (HDP) by 1) studying the association of urban/rural residence and socioeconomic status on the incidence, cardiometabolic outcomes, and post-partum care access across HDP subtypes and 2) conducting qualitative interviews to identify related social determinants of health barriers in rural settings for future targeted intervention in a large, multi-site, and largely rural practice in the Midwest.